IMPLEMENTATION AND SUSTAINABILITY OF POSITIVE BEHAVIOR SUPPORT IN REAL EARLY CARE (INSPIRE)

The goal of this study is to understand the use of positive behavior support (PBS) practices, as well as challenges and barriers that impact PBS practice implementation, in early care and education programs. Three objectives guide this project: 1) Develop a survey tool to examine the status of implementation and sustainability of PBS practices in Kansas Child Care and Head Start programs. 2) Examine program characteristics that are associated with quality implementation and sustainability of PBS practices. 3) Identify challenges and facilitators that impact implementation and sustainability of PBS practices. Mixed methods research design will be used to obtain and integrate qualitative and quantitative data to expand the field's knowledge of real-world implementation of PBS practices.